Unraveling the Genetic Programs Engaged in ASD Neurons Through Coupled Transcriptomic and Phenotypic Readouts

Autism spectrum disorders (ASD) are genetically diverse, characterized by both rare variants of large effect size
and common variants of small effect size. Identifying the molecular mechanisms resulting from these variants
presents a key challenge for the development of clinical interventions. Human pluripotent stem-cell derived
neurons (hPSC-Ns) allow studies against a human genetic background, and show altered morphology and
electrophysiology in ASD conditions. However, identifying mechanisms remains difficult with small numbers of
lines, especially for common genetic variants. To overcome this challenge, we will leverage multi-omic
characterization of hPSC-Ns perturbed with CRISPRi knockdown of both large effect size ASD risk genes and
genes related to neuronal morphology (Aim 1) and electrophysiology (Aim 2). We will complement these screens
with a characterization (Aim 3) of a larger, diverse cohort of 46 ASD lines and 46 matched controls which do not
harbor coding variants in the genes perturbed in the previous Aims. An integrative analysis of this data (Aim 4)
will generate interpretable genetic signatures related to each of these phenotypes and will show how these
signatures interact with ASD risk genes. This approach is made possible by new techniques for pooled stem cell
culture developed in Dr. Ralda Nehme’s lab, high content optical profiling methods developed by Dr. Samouil
Farhi’s team, and data integration tools developed by Dr. Ernest Fraenkel’s group. The overall project will provide
a basic neurobiological understanding of hPSC-Ns; provide valuable insight into how both common and rare
variants induce observed cell-intrinsic phenotypes; and define an analytic framework and genetic signatures
which can be used to understand mechanistic recruitment of new genetic risk loci and other psychiatric diseases.

Public health relevance
In this proposal, we seek to understand the cellular programs engaged in autism spectrum disorder (ASD) by modifying the expression of hundreds of ASD relevant genes and measuring the effect on multiple cellular phenotypes in human neurons. We use innovative technologies to couple transcriptomic and morphological or electrophysiological readouts. We use the resulting datasets to finely annotate gene ontologies for these biological processes, and determine their disruption by neurons with reduced expression of defined ASD risk genes and neurons from patients with ASD.